The Add Health Epigenome Resource: Life course stressors and epigenomic modifications in adulthood

Abstract
Disparities by race/ethnicity and socioeconomic status exist across a range of cardiometabolic and mental
health outcomes in adulthood, and have been traced to exposure to psychosocial stressors across the life
course. The discovery of the epigenome provides a remarkable opportunity to identify the pathways by which
psychosocial exposures get into the body to produce inequalities in health and disease. However, a major
limitation of extant research on life course exposures and epigenetic modifications has been a dearth of
prospective social and contextual data collection. Indeed, the majority of existing social epigenomic studies
focus on an exposure at a single life stage or rely on retrospective report of only a few indicators of early life
socioeconomic status. To more fully understand the ways in which psychosocial stressors influence the
epigenome, it is paramount to connect rich longitudinal data on psychosocial stressors with epigenetic data
and markers of health and disease. Our proposed research will examine “allostatic load”-related gene DNA
methylation (DNAm) and expression relevant to life course psychosocial stressors, among participants in the
National Longitudinal Study of Adolescent to Adult Health (Add Health). Specifically, our proposal seeks to
uncover the impact of life course psychosocial stressors on functional epigenomic alterations, and to identify
the epigenomic bridges that link psychosocial stressors with the emergence of poor mental health and
cardiometabolic conditions in the US population. We hypothesize that exposure to psychosocial stressors
across the life course, will be associated with allostatic load-related gene DNAm, and that these
patterns will vary significantly by race/ethnicity and sex. Moreover, we hypothesize that life course
stress-related methylation differences will be associated with cardiometabolic and mental health
outcomes, and partially mediated by gene expression. We will test these hypotheses through the following
specific aims: (1) Conduct DNAm testing and assess variation by age, race/ethnicity, sex, and SES among
4,200 Add Health participants; (2) Assess whether life course psychosocial stressors (e.g. socioeconomic
adversity, trauma) are associated with DNAm in allostatic load genes among Add Health participants, including
a subset of siblings and twins; and (3) Examine whether allostatic load gene DNAm is associated with
cardiometabolic health and depression measures in adulthood. We will also assess whether these associations
are mediated by gene expression. Overall, our proposal will provide an unprecedented epigenetic resource
available to the global scientific community, and will identify novel pathways by which life course psychosocial
stressors influence functional- and health relevant DNAm in the largest US nationally representative,
racially/ethnically-diverse longitudinal study of social exposures on health.

Public health relevance
Project Narrative The overall goals of this project are to investigate the influence of life course psychosocial stressors on DNA methylation and gene expression that may influence cardiometabolic health and depression in a US representative study of young adults. The findings from this study will have significant and lasting public health implications because our proposed testing of DNA methylation will be carried out in the largest sample of young adults in the US and made available to the global scientific community. The proposed research will inform our understanding of life course stress-related epigenetic and expression pathways, with potential for use in future prevention, diagnosis, and treatment of cardiometabolic conditions and depression.